Serious gaming for chemotherapy-induced nausea and vomiting in older adults with cancer: A randomized clinical trial

Project Summary
Older adults are at higher risk of toxicity and progressive severe effects related to cancer treatment.
They experience numerous side effects from cancer treatment including chemotherapy-induced
nausea and vomiting (CINV), but often undermanage it because they do not believe their actions to
self-manage CINV will be effective. Many older adults report taking anti-nausea medication only
when CINV is severe and some adopt a ‘watchful waiting” strategy as they wait for CINV to go away on
its own. This lack of self- management leads to reduced daily functioning, reduced adherence to
treatment, increased healthcare use (emergency department and hospital admissions) and cost, and
lower quality of life. There is a critical need for new strategies to assist older adults in engaging in
more active preventative and self-management behaviors at home to reduce negative outcomes. Our
team developed and tested a serious game intervention that directly addresses older adults’ erroneous
beliefs about CINV management. The eSSET-CINV intervention is a technology-based educational
simulation in which older adults learn to apply what they have previously learned about CINV self-
management strategies to an avatar who is at high risk for nausea at home after chemotherapy.
Players make decisions to prevent CINV and to self-manage it when it occurs. Our preliminary study
showed that older adults who were exposed to the eSSET-CINV intervention used twice as many
CINV preventative strategies than those who did not get the intervention. The goal of this study is to
determine the eSSET-CINV’s effectiveness at reducing CINV severity and healthcare use and
increasing functioning and quality of life. We will use a 2-group (intervention, attention control)
randomized clinical trial design. Aim 1 of this study is to examine changes in CINV severity, self-
management behaviors, functioning, QOL, cognitive representation and healthcare use within the
intervention group from baseline to completion of the study. Aim 2 is to determine efficacy of the
eSSET-CINV intervention by comparing differences in primary outcomes (CINV severity, healthcare
use) and secondary outcomes (self-management behaviors, functioning, and QOL) between groups at
each follow-up visit and completion of the study. A sample of 500 older adults will be recruited. The
intervention group will receive the eSSET-CINV at baseline, the attention control will receive it at the
end of the study. Both groups will be followed for 6 months. Our long-term goal is to develop unique,
culturally relevant serious games that allow older adults to practice making side-effect related self-
care decisions at home in a no-risk simulated environment. This research addresses the NIH research
priorities facilitating changes in cancer symptom prevention and self-management through increasing
positive health behaviors and improved health outcomes in an understudied population.

Public health relevance
Project Narrative Older adults with cancer are at risk for severe negative outcomes related to chemotherapy-induced nausea and vomiting (CINV) during treatment with chemotherapy due to poor self-management. Early reinforcement of standard education and reframing preconceived beliefs about the ability of CINV to be successfully managed through serious games will increase self-care behaviors and improve patient outcomes. The purpose of this study is to investigate the effectiveness of a serious game intervention in reducing CINV severity and healthcare use and increasing functioning and quality of life in older adults.